Brain Metabolites and Temperature Changes in Obstructive Sleep Apnea Adults

PROJECT SUMMARY/ ABSTRACT
Obstructive sleep apnea (OSA), a life-threatening condition, affects ~10% adults in the United States. The
condition is accompanied by multiple symptoms (autonomic, breathing, mood, and cognition), which are linked
to increased morbidity and mortality and decreased quality of life. The impaired functions likely result from
brain changes in sites that mediate these regulations, but the pathological mechanisms contributing to brain
changes are unclear. Intermittent hypoxia (IH), a primary characteristic of OSA, induces oxidative stress,
leading to excessive production of reactive oxygen species (ROS) that encourages neuroinflammation and
activates immune and glial cells; that sequence leads to regional increases in brain temperature, contributing
to tissue damage. Moreover, IH induces mitochondrial dysfunction, altering metabolites, including the N-acetyl-
aspartate (NAA; neuronal integrity), choline (Cho; membrane metabolism/integrity/turnover), creatine (Cr;
energy metabolism), myo-inositol (MI; astrocyte proliferation/osmotic balance), and lactate (Lac; anaerobic
metabolism). Also, antioxidants, including glutathione (GSH) that plays a significant role against oxidative
stress, regulate neuronal/cellular protection from excessive ROS. However, the distribution of regional brain
temperatures, metabolites, and antioxidant status in OSA is unknown, leaving a gap in knowledge of sources
of injury that can be examined non-invasively with the 3D Echo Planar Spectroscopic Imaging (3D EPSI) and
the MEshcher–GArwood Point RESolved Spectroscopy (MEGA-PRESS). Therefore, using 100 moderate-to-
severe OSA and 100 age- and sex-matched controls, the specific aims are to: 1) examine regional brain
temperatures, using 3D EPSI, in OSA and controls; 2) assess whole-brain metabolites (NAA, Cho, Cr, MI, and
Lac), using 3D EPSI, antioxidant (GSH) levels from the posterior and anterior cingulate and anterior insula,
using MEGA-PRESS, in OSA and controls; 3) determine the relationships between brain temperatures and Lac
and MI levels with disease severity in OSA adults; and 4) assess regional brain temperature and metabolites
changes, using 3D EPSI, after 6-months in OSA with and without continuous positive airway pressure (CPAP)
compliance. In summary, the objective is to examine IH-induced oxidative stress and mitochondrial dysfunction
processes contributing to brain changes in OSA, reflected as changes in regional brain temperatures and
metabolites, and antioxidant in multiple brain sites, links between brain temperature, metabolites, and disease
severity, and assess if the CPAP normalizes such changes in OSA. The findings have important implications
for identifying interventions (nonsteroidal anti-inflammatory drugs, antioxidant, and Cr therapies as used in
other conditions) to fully rescue brain changes in OSA with and without CPAP in those sites, which will benefit
to dysfunctions, especially in non-CPAP compliant OSA or no treatment, and could dramatically improve the
morbidity, mortality, and life quality.

Public health relevance
PROJECT NARRATIVE Obstructive sleep apnea is a life-threatening condition, disrupting multiple autonomic, mood, breathing, and cognitive functions, most likely from tissue and functional alterations in brain sites that regulate these functions, which are linked to morbidity, mortality, and quality of life. The pathological processes that induce such brain changes in obstructive sleep apnea are unclear, but likely include intermittent hypoxia-induced oxidative stress and mitochondrial dysfunction; those aspects can be evaluated by assessing regional brain temperatures, metabolites, and antioxidant levels, links between temperature, metabolites, and disease severity, as well as examining the effect of continuous positive airway pressure, the gold standard intervention for obstructive sleep apnea, on brain temperature and metabolites. The outcomes will have important implications for identifying effective interventions to rescue brain injury, especially in obstructive sleep apnea patients with non- compliant continuous positive airway pressure or no treatment, with subsequent benefits for dysfunctional physiology and behavior, and could dramatically improve the morbidity, mortality, and quality of life in the condition.